TWENTY FOUR HOUR AMBULATORY BLOOD PRESSURE MONITORING IN CHILDREN WITH IDDM

This protocol will ascertain if blood pressure in children and adolescents with IDDM is significantly higher than age matched controls without IDDM when monitored over a 24 hour period using and ambulatory blood pressure monitoring device.